Consumer-Therapist-Connector: Increasing Access to Quality Behavioral Healthcare

ABSTRACT
The United States is experiencing a major mental health crisis. Per recent reports in the New
York Times and The Washington Post, the gap between need and access to behavioral health
services is rapidly increasing. There is an urgent need to solve both the access and quality
problems with behavioral healthcare. With COVID and other stressors, 76% of surveyed
employees are reporting at least one significant behavioral health symptom and 27% believe
their employer is not doing enough to assist their family with their anxiety, depression, and other
behavioral health issues. Another report indicated that adults are on wait lists for 3+ months to
receive outpatient therapy in Massachusetts. There simply are not enough therapists to meet
the growing demand and waiting lists are long and growing. On the quality side, more than 60%
of patients find no meaningful benefit from the treatment they receive. We have already created
a system that dramatically improved the quality problem in a randomized clinical trial: this
referral process roughly doubled network outcomes for the primary referral channel for the
Cleveland Clinic, improving outcomes compared to a control group where cases were assigned
based on therapists self-perceived strengths. In the current application we aim to solve the
access problem by developing Consumer-Therapist-Connector. This innovative online tool will
expeditiously connect patients with well-matched therapists for traditional therapy by distance
search, or telemedicine by state or national searches. What distinguishes our solution from
other online find-a-therapist systems is that the patient can be easily added to the waitlist of all
empirically well-matched providers, which increases the likelihood they will connect quickly with
a good-fitting therapist. It will alleviate the growing anguish patients encounter when calling
numerous providers only to learn that their practices are full. At the same time, these waiting
lists will dramatically increase the opportunity to use our proven matching technology to
simultaneously improve quality, encouraging consumers and providers to offer and accept
appointments only when a match is likely to greatly benefit the patient.

Public health relevance
PROJECT NARRATIVE We propose to develop an innovative tool called Consumer-Therapist-Connector to increase consumer access to the therapists who have had patients with successful therapeutic outcomes in the consumers’ specific area(s) of need. Waitlists, while frustrating, are unavoidable in the current marketplace given serious supply and demand inequities for behavioral health care. Within this new flexible, secure, online system, we will reduce the administrative burden on vulnerable patients and overbooked therapists, while maximizing therapy access and quality.